Mechanisms and therapeutic potential of phrenic proprioceptors after spinal cord injury

PROJECT SUMMARY/ABSTRACT
Breathing impairments are the primary cause of morbidity and mortality following cervical spinal cord injury
(cSCI). Limited treatment options, beyond mechanical ventilation, are available to manage respiratory
dysfunction. Electrical stimulation of the diaphragm (i.e., diaphragm pacing), is an emerging intervention used to
manage breathing impairments in some individuals who fail to wean from the mechanical ventilator after cSCI.
Clinical reports suggest that diaphragm pacing can promote ventilator weaning, but also shows promise in
restoring independent breathing. Collectively, our preliminary data and literature reports have led to the
fundamental hypothesis that diaphragm sensory neurons (i.e., phrenic afferents) are a novel therapeutic target
to restore respiratory neural function and improve breathing following cSCI. Specifically, our preliminary data in
anesthetized rats suggest that activation of phrenic proprioceptors induces a novel form of phrenic motor
plasticity. Our data also show that daily diaphragm pacing in freely behaving rodents leads to a long-lasting
increase in tidal volume after cSCI. Moreover, we show that activation of phrenic afferents is necessary for
pacing-induced respiratory recovery. Finally, preliminary data demonstrate that phrenic afferent discharge is
profoundly altered after cSCI and that diaphragm pacing restores discharge patterns necessary for the induction
of plasticity. These results have led to the overarching hypothesis that phrenic proprioceptors induce
mechanisms of spinal plasticity which promotes the recovery of breathing after cSCI. Aim 1 will test the
hypothesis that phrenic proprioceptor activation induces a novel form of phrenic motor plasticity which is
mechanically distinct from other forms of respiratory plasticity. This hypothesis will be tested using in vivo
neurophysiology to enable studies examining spinal mechanisms of plasticity. Aim 2 will test the hypothesis that
respiratory proprioceptors are necessary for diaphragm-pacing induced respiratory recovery. This hypothesis
will be tested using a rodent model of daily, diaphragm pacing in freely behaving rodents and adeno-associated
virus (AAV) mediated chemogenetic approaches to silence respiratory proprioceptors. Aim 3 will test the
hypothesis that phrenic proprioceptor activity is altered following cSCI and diaphragm pacing promotes discharge
in phase with breathing. This hypothesis will be tested using a neurophysiological approach to record phrenic
afferent discharge and deliver diaphragm pacing. Our research will identify a novel target to improve breathing
following cSCI and has the potential to lead to a paradigm shift in the management of breathing insufficiency
after cSCI – a problem with limited treatment options and no cure.

Public health relevance
PROJECT NARRATIVE Spinal cord injury in the cervical region is particularly devastating due to paralysis of the primary inspiratory muscle, the diaphragm and few strategies are available to improve breathing. In an animal model, we demonstrate that activation of neurons carrying sensory information from the diaphragm leads to long-lasting improvements in breathing. Our proposed studies will investigate the mechanisms which give rise to these improvements and explore the use of diaphragm sensory neurons as a novel treatment strategy to restore diaphragm function following cervical spinal cord injury.